Academy of Aphasia Research and Training Symposium

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
PROJECT ABSTRACT
The annual Academy of Aphasia meeting is the premier conference for researchers in the field of language processing and aphasia. Since the first meeting in 1963, this international meeting has brought together an interdisciplinary group of linguists, psychologists, neurologists, and speech-language pathologists to discuss the latest research in the field of aphasia, including theoretical, clinical, and rehabilitation aspects of this language disorder. The topics at the conference range widely but almost always cover all aspects of language processing including phonological processing, lexical-semantic processing, syntactic processing, orthographic processing, bilingualism, computational modeling, non-invasive and invasive brain imaging, language recovery, neuroplasticity, and rehabilitation. In this renewal proposal, we continue with two initiatives implemented in the first cycle of the grant which have been very successful and introduce a third initiative (“Panel discussions regarding success in academia”) to continue to build the research and training caliber of early-career aphasia researchers. We continue our first initiative that involves a formal mentoring program for early-career investigators entering the field of aphasia research. In this program, selected student/post-doctoral fellows from different areas of aphasia research who are first authors at the conference are paired with a mentor. This mentor will provide specific feedback about the mentee’s presentation and general mentorship to the mentee about research and academic careers. This program has received very positive feedback in the past five years of the grant cycle with long term benefits for the early-career researchers. The second initiative we continue will be an hour-long seminar (New Frontiers in Aphasia Research) that covers the background and approach of a state-of-the-art methodology, that has an application to the study of aphasia. Given the highly interdisciplinary nature of aphasia research, these workshops will bridge the communication between aphasia researchers and scientists and experts who have developed new approaches to study the brain. The third and new initiative will be a “Panel discussions regarding success in academia” where each year we discuss current topics fostering success in academia. Over the five years, we will invite editors of journals, reviewers on different funding panels to discuss important topics such as open access publishing the use of artificial intelligence in academic research. In the last five years, the NIDCD program has changed the fabric and energy at the conference for the better and has established a process to ensure a pipeline of highly talented and trained scientists pursuing a research or clinical career with strong foundations in interdisciplinary research on aphasia. This renewal application continues this important work.

Public health relevance
The annual academy of aphasia conference brings together innovative and interdisciplinary scientists across the world come together to discuss the latest advances to understand, diagnose and treat aphasia. The NIDCD funded program provides a unique opportunity for early-career scientists to learn from senior researchers, learn state-of-the-art research methods and network with other outstanding scientists pursuing aphasia research.